Communication in American Indians thru Strategies for Equity 4 Cancer (CASE4Cancer)

PROJECT SUMMARY:
Cancer continues to be the top cause of death for American Indians (AIs) in North Carolina. With higher rates
of colorectal cancer (CRC) late-stage diagnosis and mortality and the highest smoking rate among all
race/ethnic groups in the state, there remains a critical need to reduce the use of tobacco among AIs while also
improving early detection of lung and CRC cancers in order to improve disparities and outcomes. The Atrium
Health Wake Forest Baptist Comprehensive Cancer Center’s (AHWFBCCC) Community Outreach and
Engagement (COE) efforts are focused on addressing the disproportionate burden of cancer in the catchment
area. NC has the largest AI population east of the Mississippi River, making addressing the cancer-related
health needs of AI communities critical to this mission. Our recent integration with Atrium Health presents a
unique opportunity to leverage complementary strengths across both cancer campuses to expand our reach by
building on existing foundational collaborations and activities. Together, we propose to apply an innovative,
multi-channel outreach and educational campaign to increase cancer awareness, preventive behaviors, and
lifesaving screenings, to help address cultural and demographic issues contributing to disparities in health
literacy and cancer in AIs. To accomplish this, we have two Specific Aims: 1) Implement a culturally tailored
communication campaign tailored to tribal communities in the catchment area and region to improve health
literacy, increase awareness about cancer screenings, and promote preventive lifestyle behaviors focused on
lung, colorectal, and head and neck cancers, and 2) develop a tribal liaison program for continued local cancer
education and screening support that will increase cancer awareness, preventive behaviors, and screenings by
linking underserved AI communities to state-of-the-art evidence-based cancer screening and tobacco
cessation. By employing a framework for equity-centered health communication, we will partner with our tribal
communities in an iterative process to create, implement, and evaluate culturally tailored educational cancer
communication messaging to increase cancer awareness, preventive behaviors, and lifesaving screenings.
Leveraging established infrastructure and foundational collaborations will facilitate development of a
community outreach and education intervention that is sustainable and can disseminate best practice for future
adaptation and implementation.

Public health relevance
PROJECT NARRATIVE: An innovative, multi-channel outreach and educational campaign to increase cancer awareness, preventive behaviors, and lifesaving screenings can help address cultural issues contributing to disparities in health literacy and cancer outcomes in American Indian communities in North Carolina. Utilizing an equity-centered health communication process will help ensure messaging is clear, relatable, actionable, and inclusive as part of a sustainable communication campaign with the opportunity for future dissemination, adaptation, and implementation.